Novel Lipid 2nd Messengers Regulating Bioenergetics and Signaling in Human Myocardium

ABSTRACT
Cardiovascular disease is the most common cause of death in industrialized nations. During the course of our studies,
we have identified previously undiscovered mitochondrial pathways of lipid metabolism and signaling which lead to
the generation of 2-arachidonoyl-lysophosphatidylcholine (2-AA-LPC) and 2-arachidonoyl-
lysophosphatidylethanolamine (2-AA-LPE). These include: 1) the identification of iPLA2g (PNPLA8) as a
phospholipase with sn-1 specificity; and 2) oxidized cardiolipin-activated cytochrome c serving as a plasmalogenase
catalyzing the production of 2-AA LPC and 2-AA LPE. Further research demonstrated that 2-AA-LPC and 2-AA-LPE
are excellent substrates for cyclooxygenase-2 resulting in a plethora of unanticipated metabolites. Remarkably,
incubation of these substrates with either 12-lipoxygenase or 15-lipoxygenase resulted in their oxidation to 12-
H(p)ETE- or 15-H(p)ETE-lysophospholipids. Building upon these discoveries we identified 2-AA-LPC and 2-AA-LPE
as signaling and metabolic nodes in lipid synthesis and human heart mitochondrial function. Importantly, we have
identified the ability of failing human heart mitochondria to generate increased amounts of HETE eicosanoids in
response to Ca2+ challenge in comparison to non-failing control mitochondria. Recently, ferroptosis has been
identified as a mechanism that leads to cell death through the accumulation of lipid hydroperoxides. During myocardial
ischemia and heart failure, a substantial portion of mitochondrial iron (Fe+3) is released from its bound state to become
free Fe+2 that initiates the formation of reactive oxygen species (ROS) through Haber-Weiss and Fenton-type
chemistries. The present research is targeted to identifying the roles of prominent mechanisms responsible for the
oxidized lipids and their roles in membrane dysfunction in failing myocardium. The proposed research will focus on
mechanistically understanding the mechanisms leading to oxidized lipid production in the failing human heart.
Specifically, we will identify the chiral enrichment in different classes of oxidized lipids to gain mechanistic insight into
future translational targets for therapy of heart failure. If lipid oxidation is largely enzyme-mediated, then specific
enzymes can be targeted that will be identified in the proposed research. Alternatively, if lipid oxidation is largely
mediated/initiated by non-enzymatic Fe+2 mechanisms then Fe chelation approaches and intramembrane radical
traps can be explored. In Specific Aim 3, we will investigate the roles of oxidized lipids in the activation of different cell
types from control and from failing hearts from female and male subjects. The importance of inflammation in heart
disease is now well documented, but the roles oxidized lipids play in activating different cells of the immune system
is still at its earliest stages of understanding. To traverse this gap in our knowledge, we will examine the effects of
different oxidized lipids on selected cells in the cardiovascular system (e.g., cardiac myocytes, fibroblasts, endothelial
cells, and macrophages). Through understanding the mechanisms underlying the deleterious effects of oxidized lipids
on mitochondrial function in human hearts, a multi-tiered approach for treatment of congestive heart failure can be
realized targeting enzyme-mediated oxidation, Fe2+ mediated oxidation and terminators of free radical propagation.

Public health relevance
PROJECT NARRATIVE Heart failure is the leading cause of death in industrialized societies. Our research studies the critical role of membrane abnormalities during heart failure. We have discovered new pathways that generate toxic molecules promoting the progression cardiac compromise. The proposed research is directed toward identifying several levels of new targeted approaches for the treatment of heart disease.